Postdoctoral Training in Suicide Prevention Research

As the only NIMH-funded postdoctoral training program dedicated solely to suicide prevention research,
the CSPS T32 continues to shape the field. This application is for competitive renewal (Years 21 through 25) of
an NIMH Institutional National Research Service Award (T32 MH20061) titled, “Postdoctoral Training
Program in Suicide Prevention Research.” We seek support for six postdoctoral training slots. A
component of the University of Rochester’s (UR) Center for the Study of the Prevention Suicide (CSPS), the
“CSPS T32” has as its long-term objective to develop a cadre of early career scientists with the knowledge
and experience necessary to establish careers as independent investigators and members of interdisciplinary
teams dedicated to the study of suicide and its prevention. Training emphasizes suicide prevention research
consistent with the revised NIMH Strategic Plan for Research – 2020, which calls suicide “an urgent priority for
NIMH”. Fellows in psychology, public health, medicine, and related disciplines undergo a two-year training
sequence guided by an “individual development plan” designed by each fellow and her/his mentor at the outset
of training and annually. The curriculum includes a coordinated series of courses, seminars, and workshops
designed to provide the fellow with a firm foundation in the theories and methods of suicide prevention
research. Core areas of knowledge and skill development include (a) suicidology, (b) research methods, (c)
academic career development and “survival skills”, and (d) professional integrity and the ethical conduct of
research. Each fellow works with one or more Mentors selected from the UR faculty on development and
implementation of an individually tailored program of applied suicide prevention research. A third year of
mentored research training is available on a selective basis. An evaluation plan closely tracks the performance
of each trainee and, over the longer term, of the program itself in preparing its graduates for careers in
intervention, outcomes, and health services research in general and suicide prevention studies in particular.
Suicide is a complex, multi-determined behavior. The CSPS T32 has been successful in recruiting fellows
who are from cultural and academic backgrounds that reflect the diverse perspectives needed to understand
suicide and its prevention. Retention through the program and into careers in suicide prevention research has
been excellent. Program innovations with this application include increased emphases on training in (a) the
use of digital technologies, artificial intelligence and health analytics in suicide prevention research; (b) the
translational neuroscience of suicide; (c) the role that sensory (hearing and vision) deficits play in suicide risk,
and the recruitment of fellows from those communities; and (d) the lived experience of individuals and families
affected by suicide. The fellowship is further enriched by the addition to its already robust network of
collaborators of linkages with (i) the UR Health Lab for digital technology innovation, (ii) the UR Del Monte
Institute for Neuroscience, (iii) UR Center for Eye and Brain Health.

Public health relevance
Project Narrative Suicide is the tenth leading cause of death in the U.S., second among individuals between the ages of 10 and 34 and fourth among individuals between the ages of 35 and 54. Rates of suicide have increased by over 30% in the past two decades and continue to rise. The objective of this postdoctoral fellowship is to provide scientists with the knowledge and skills to design and conduct research with the goal of reducing suicide- related morbidity and mortality across the life course.